Identification of selective inhibitors of PTH-receptor for Jansen’s metaphyseal chondrodysplasia

Summary
The objective of this project is to test and optimize our recently identified small non-peptidic molecules (re-
ferred to as Pitt molecules) to restore normal parathyroid hormone type 1 receptor (PTHR) signaling and cellu-
lar temporomandibular joint (TMJ) condylar morphogenic processes, which are defective in cells expressing
constitutive active receptor mutants causing
Jansen’s metaphyseal chondrodysplasia (JMC). Based on existing
collaborations between PIs (Dr. Vilardaga, Dept. of Pharmacology & Chem. Biol., and Dr. Taboas, Dept. Oral
and Craniofacial Sciences, and of Bioengineering) and co-I
(Wipf, Dept. of Chemistry) at U.Pitt, an interdisci-
plinary approach has been developed to demonstrate the efficacy of Pitt molecules in restoring normal PTHR
signaling and cellular morphogenic processes in vitro, and thereby better understand the effects of PTHR sig-
naling on condylar morphogenesis.
We propose 2 aims: Aim 1 will identify the most effective allosteric small molecules for blocking constitutive
PTHR activation using state-of-the-art optical analysis of receptor signaling in live cells expressing PTHR mu-
tants encountered in JMC patients (PTHR-H223R, PTHR-T410P, or PTHR-I458R), and medicinal chemistry
methods to optimize blocking properties of Pitt molecules. Aim 2 will take a step further by determining the ef-
fect of small molecules on temporomandibular joint condylar morphogenesis using biochemical and histological
assays on engineered microtissues composed of condylar mesenchymal progenitors from wild-type and mice
expressing the JMC mutant PTHR-H223R.
The significance of this research program lies in its premise to better understand the effects of PTHR signaling
on condylar morphogenesis and lay the groundwork for a future translational research program that examines
the therapeutic utility of these Pitt molecules for treatment of temporomandibular disorders.

Public health relevance
Narrative Jansen's metaphyseal chondrodysplasia (JMC) is a rare autosomal disorder characterized by malfunction of the temporomandibular joint (TMJ) among other bone deformities that are associated with hypercalcemia and hypophosphatemia. Caused by constitutive activation of genetically dominant heterozygous mutants of the parathyroid hormone (PTH) type 1 (PTHR) receptor, the cell surface receptor for PTH and its related protein (PTHrP), there is no cure or efficient therapeutic drug for JMC patients. The goal of this project is to identify effective small (non-peptidic) molecules for directly blocking anomalous constitutive activity of PTHR JMC mutants while maintaining the action of endogenous ligands (PTH and PTHrP).